YES in THE HEIGHTS

The mission of the NCI Youth Enjoy Science (YES) in THE HEIGHTS program at the Herbert Irving Comprehensive Cancer Center (HICCC) is to reduce the cancer burden and address health disparities in the HICCC Catchment Area (CA) by expanding access to training and mentorship opportunities for students and teachers. Our program is grounded on the commitment to address multiple levels of cancer causes, starting from the social determinants of health (SDoH) to the community, household, and individual chemical and physical environmental exposures that interact with lifestyle and underlying cancer susceptibility. Our approach emphasizes multiple levels of causation with multiple levels of risk reduction and modification across the life course including the following themes: (1) SDoH as drivers of cancer health disparities; (2) Multiple levels of interventions to address cancer health disparities through research, training and dissemination at the community, school, family and individual level; and (3) Life course approaches to cancer risk reduction that incorporates health ambassador and citizen scientist approaches and engages high school and undergraduate students in community relevant health education and field work. We are excited by the opportunity to expand the HICCC CURE Program through research experiences (Goal 1), curriculum development (Goal 2), and outreach and engagement (Goal 3). We will continue our commitment to mentoring students, including students from nearby City University of New York (CUNY), the largest urban public university system in the U.S. We have also designed the YES in THE HEIGHTS program with novel pedagogical and experiential training in cancer health disparities and basic science for grade 9-12 science teachers within the Math and Science for America (MfA) Program. Across all five years, YES in THE HEIGHTS will mentor, train and engage over 1,125 individuals within the communities we serve. To accomplish these goals, our program will be grounded on 5 key principles: (1) It takes a village to guide students through to academic success; (2) Active mentorship; (3) Foundational training; (4) Team science research; and (5) Program evaluation. The MPIs Terry and McDonald have successfully run the HICCC CURE program since 2015 and have extensive background in teaching and mentoring recognized as Mentor of the Year at Mailman School of Public Health and CU Presidential Teaching Award, respectively. They are joined by an esteemed group of faculty members who have offered to serve as mentors for this R25 program, all with varied areas of scientific research expertise including exposure sciences, toxicology, environmental and molecular epidemiology, participatory research methods, and biomedical sciences. YES in THE HEIGHTS expands the proven success of HICCC CURE which has trained 50 students since 2015 in research laboratory experiences and over 400 students in online scientific enrichment.

Public health relevance
The mission of this new NCI Youth Enjoy Science (YES) THE HEIGHTS program at the Herbert Irving Comprehensive Cancer Center (HICCC) is to help reduce the cancer burden and address health disparities in the HICCC Catchment Area (CA) by expanding access to training and mentorship opportunities for students and teachers. The program builds on academic partnerships, including with the City University of New York (CUNY), the largest urban public university system in the U.S., and collaborates with the Math and Science for America (MfA) Program to develop novel training programs for high school students. Across all five years, YES in THE HEIGHTS will mentor, train and engage over 1,125 individuals from the communities we serve.